Metabolic control of tRNA-mediated translational reprogramming in glioblastoma

ABSTRACT
Glioblastoma (GBM) ranks among the most lethal of human cancers. Standard-of-care therapies offer only
palliation and molecularly targeted treatments have shown little benefit for patients. The failure to achieve
tumor control is partly due to the presence of GBM stem cells (GSCs). These stem-like cells self-renew and
differentiate into diverse cell types within the tumor, generating intratumoral heterogeneity and contribute to
angiogenesis and immune escape. Although the impact of GSCs remains controversial, defining their
molecular regulation may offer novel therapeutic paradigms to improve the clinical care of patients afflicted
with GBMs and other brain tumors.
We and others have found that GSCs are distinguished from their differentiated progeny and normal neural
stem cells at multiple levels of regulation, including transcription, epigenetic, epitranscriptomics, translational,
and post-translational mechanisms. In preliminary studies, GSCs display enhanced protein synthesis relative
to differentiated progeny and neural stem cells, suggesting that efficient mRNA translation may contribute to
tumorigenesis. During translation, tRNAs decipher genetic codes by base pairing with mRNA codons and
transfer the corresponding amino acids to the growing peptide chain. Post-transcriptional tRNA modifications
regulate their translational functions, which are cell-type specific and influenced by environmental cues.
Aberrant modifications alter tRNAs stability, structure, and folding to restrict or expand decoding.
This proposal focuses on a currently understudied area of tRNA modification in GBMs. Comparing expression
profiles of disease-related tRNA-modifying enzymes, I identified differentially expressed tRNA-modifying
enzymes and marks in patient-derived GBM surgical samples and cultures. As selected amino acids serve
as co-factors for tRNA modifications, I hypothesize that dietary restriction of amino acids can reprogram the
tRNA landscape. Indeed, in preliminary studies genetic targeting of tRNA modification enzymes or amino
acid restriction reduced GSC proliferation, self-renewal, and in vivo tumor growth. tRNA modifications can
specifically target a subset of tRNAs, so I also hypothesize that altered tRNA modifications change
homeostasis of tRNA pools and lead to codon-biased reprogramming of translation that drive oncogenic
processes in GBM. To test this hypothesis, I will use mass spectrometry to detect changes in tRNA
modifications and ribosome profiling to understand downstream proteomic changes upon tRNA enzyme
knockdown and diet restriction. Collectively, this proposal will provide molecular insights into roles of tRNA
modifications in cancer stem cell maintenance and inform development of novel therapies for GBM.

Public health relevance
PROJECT NARRATIVE Glioblastoma ranks among the deadliest of all human cancers, with no effective treatment. I will study roles of a tRNA modification enzyme in maintaining stemness and promoting growth of cancer stem cells in glioblastoma. This study will inspire the design of potential new treatments for patients afflicted with glioblastoma.